Sequencing Familial Lung Cancer

Lung cancer (LC) is the leading cause of cancer mortality in the U.S. Although tobacco smoking and some
environmental exposures contribute substantially to lung cancer risk, family studies show an additional strong
contribution from genetic factors. The Genetic Epidemiology of Lung Cancer Consortium (GELCC) has been
collecting samples and data from individuals with a strong family history of LC for the last 20 years, and has
assembled a unique resource of specimens and data. We have cancer phenotypes, smoking exposure data
and biological specimens available on multiple relatives in over 150 highly aggregated LC families (high-risk
familial lung cancer families, HRFLC cases/families) as well as phenotype, genotype and smoking data on
over 800 additional lung cancer cases who have a family history of at least one first or second degree relative
with lung cancer but for whom biospecimens were not available from additional relatives (familial cases from
biospecimen limited families, FLC cases). The goal of this research application is to identify genetic
factors that confer a high risk for lung cancer and to perform research to characterize further the
mechanisms by which these factors influence lung cancer risk. Identifying genetic factors for lung cancer
provides insight into the specific causes and pathways underlying its development. In addition, if high-risk
individuals can be identified they will reap the greatest benefit from screening modalities.
We propose three aims. In aim 1 we will identify genetic factors conferring a high-risk of lung
cancer development.. In this aim, we will complete analyses of WES data from 33 HRFLC families
comprising 291 individuals along with 114 FLC cases and case/control analyses of 1084 lung cancer cases
compared with 919 controls. We will use these data along with linkage analysis to prioritize uncommon variants
that have a strong effect on lung cancer risk. In Aim 2 we will extend and validate findings to a broader
population. We will also collect additional samples from LC cases in HRLFC. We will sequence the most
strongly associated variants and genes from Aim 1 in additional affected and unaffected individuals in the
sequenced families and an additional set of FLC cases and frequency matched controls. This aim will allow us
to a) validate findings from aim 1 using a larger collection of cases with a family history of lung cancer and
controls and b) assess the impact on risk in families according to smoking behavior and genetic contributions.
In Aim 3 we will study the impact that variants found in aims 1 and 2 have on cellular biology. We will
study the effect that specific mutations have on cellular phenotypes identified in aims 1 and 2 using CRISPR
technology. We will begin by studying mutations in PARK2 that we recently identified in 5 HRLFC families and
in E2A we previously studied. The proposed research will bring new insights into the etiology of lung cancer.

Public health relevance
NARRATIVE Although tobacco smoke exposure is the most important risk factor for lung cancer inherited genetic factors also play a role as shown by many family and genome wide association studies. The proposed studies will detect novel rare genetic factors, examine interactions between smoking history and the rare genetic factors and evaluate the impact on the cellular phenotypes of these mutations.